Neighborhoods and Cardiovascular Risk and Resilience in Rural Communities

Project Summary
The higher burden of cardiovascular disease (CVD) in rural areas, particularly in Appalachia and the
Mississippi Delta is alarming, yet virtually nothing is known about the underlying factors contributing to this
rural health penalty. Prior research has shown that neighborhood environments are important drivers of CVD
risk and racial/ethnic disparities in CVD; however, this work has been conducted almost exclusively in urban
cohorts, leaving ~20% of the population understudied in regard to the #1 cause of mortality in the US. It
remains unknown whether traditional features of neighborhood environments (e.g., food access, crime, social
cohesion) operate similarly in rural areas to impact CVD risk, and this must be investigated rigorously. There is
also an urgent need to better understand the role of more unique features of rural communities, such as geo-
spatial isolation of residences, distance between businesses and retail outlets, and social networks operating
in these contexts. It is important to characterize these unique rural neighborhood typologies and to investigate
which subgroups may be most vulnerable to the cardiovascular health impacts of different neighborhood
archetypes. We will examine whether associations are more deleterious among those who are psychosocially
vulnerable – those with high levels of childhood trauma or inadequate social support. Finally, factors that
contribute to cardiovascular resilience have also been understudied and we have a unique opportunity to
investigate the multi-level factors that may contribute to CVD resilience (optimism, purpose in life, resilient
coping). Thus, the overarching goal of the proposed study is to: 1) examine the relationship between
neighborhood factors and unique neighborhood typologies on cardiovascular health (CVH) in rural
communities, 2) determine which groups are most psychosocially vulnerable, and 3) determine whether the
impact of adverse neighborhood typologies on CVH and subclinical CVD is mitigated by psychological
resilience. The final, exploratory goal of this study is to 4) assess if associations are modified by age, sex, or
race/ethnicity. To achieve these goals, we will leverage existing data from the Risk Underlying Rural Areas
Longitudinal Study (RURAL) that will recruit 4,600 individuals ages 25-64 from 10 rural counties in Appalachia
and the Mississippi Delta of the United States. We will augment this rich rural cohort by linking new data
sources (e.g., geo-spatially referenced databases) and creating new measures in order to provide a
comprehensive database of indicators of neighborhood physical and social environments. All in all, this work
may help provide a more nuanced understanding of the multi- level determinants of both CVD risk and
resilience and may help to identify novel levers of intervention to improve cardiovascular health in rural
communities.

Public health relevance
RELEVANCE: Given the disproportionate burden of cardiovascular disease in rural areas, particularly in the southeastern portion of the United States, the proposed study will examine whether features of neighborhood physical and social environments are associated with CVD risk and subclinical disease burden in rural communities, and which groups are most vulnerable and resilient to the health impacts of these environments. Findings from this research may help to elucidate the key contextual drivers of cardiovascular risk and resilience in rural communities.